Enantioselective Catalytic Chlorosilane Reactions

Hypervalent silicon complexes generated from Lewis base catalysts and chlorosilanes
are very reactive intermediates and continue to be an important source for the
development of new chemical methodologies in organic synthesis. The unique reactivity
profiles, low-toxicity and ready availability of chlorosilanes have yielded an impressive
array of chemical methods and processes. This proposal seeks to innovate the ability of
chlorosilanes to deliver carbon nucleophiles under Lewis base catalysis conditions
through integrated experimental and computational investigations, and to apply it to
novel condensation reactions with readily available N-acylhydrazones. These
challenging transformations will be rendered enantioselective through the development
of conceptually new classes of chiral Lewis base catalysts. The utility of the resulting
methods will be demonstrated by the asymmetric synthesis of biologically relevant
molecules. Goals of the research program include advancing Lewis base catalysis of
chlorosilanes at the fundamental level, and new reaction development that will provide
rapid, efficient access to novel chiral building blocks bearing the hydrazine/amine-
substituted tertiary and quaternary stereocenters. We will focus on the transformations
that can provide chiral synthetic intermediates that are either inaccessible or very difficult
to obtain with currently available methods. The results are expected to transform the way
chlorosilanes are utilized in asymmetric synthesis.

Public health relevance
One of the most critical issues in the drug discovery and development is a lack of reliable, efficient chemical synthesis methods. This proposal seeks to develop new methods to synthesize complex chiral hydrazines and amines in a single hand form with high efficiency from readily accessible starting materials.